Harmonizing and Archiving India Human Development Surveys

PROJECT SUMMARY This R03 will harmonize and archive data collected under four NICHD funded projects that created the India Human Development Surveys (IHDS) Wave 1 of 2004-5 and Wave 2 of 2011-12. These publicly available data have been among the most commonly downloaded surveys in the data archive of the Data Sharing for Demographic Research (DSDR). The proposed funding would: (1) Harmonize variables and personal identifiers across the two waves of IHDS surveys; (2) Develop additional documentation and provide improved user support including a web based user forum; (3) Use confidential data available to the IHDS team to create a consolidated fertility history file for women interviewed during both surveys; and (4) attach personal identifiers and reformat files of household nonresidents and migrants to enable panel analyses across waves.

Public health relevance
NARRATIVE This project will prepare data files and documentation for wider public use of the NICHD funded panel survey, India Human Development Surveys Wave 1 and Wave 2. These survey data have already become one of the most widely used public data files supported by NICHD. The improvements in documentation and data file construction will further ease users’ access to these data and provide new opportunities for analyses of birth histories and household structure.